Type 1 Diabetes in Acute Pancreatitis Consortium – Pacific Northwest Clinical Center: Immune Pathogenesis of Post-Pancreatitis T1D

PROJECT SUMMARY
Acute Pancreatitis (AP) accounts for over 300,000 hospitalizations in the United States per year. Along with the
morbidity and mortality occurring at the time of AP hospitalization, in recent years, evidence has indicated that
development of diabetes mellitus (DM) is relatively common after an episode of acute pancreatitis; estimates
range from 10-40% of people with AP developing DM. As evident from the wide-ranging estimates, the degree
of risk of DM, and factors driving that risk, have not been definitively identified. Characterization of the type of
DM that develops after AP, whether Type 1 diabetes, Type 2 diabetes, or Type 3c diabetes (associated with
destruction of the exocrine pancreas), has not been done in large, prospective cohorts. Retrospective
studies/meta-analyses of DM suffer from a difficulty in appropriate classification of diabetes via review of
electronic health records, making it challenging to have full confidence in these studies. The role of the immune
system in AP, and in the development of DM after AP, also remains poorly understood, with few publications
detailing the immune response to AP using modern immunophenotyping methods. For these reasons, the Type
1 Diabetes after Acute Pancreatitis Consortium (T1DAPC) was initiated to develop and conduct a longitudinal
prospective study into the incidence, risk factors, and immune and endocrine variables associated with the
development of DM after AP.
The 10 clinical centers of the T1DAPC have now enrolled over 750 participants into a clinical research protocol
called Diabetes Related to Acute pancreatitis and its Mechanisms (DREAM). The DREAM study calls for
enrollment of participants within 90 days of an AP hospitalization, with longitudinal follow-up for 5 years to identify
changes in glucose tolerance and the development of diabetes. It also seeks to characterize the endocrine and
immunologic features associated with AP and post-AP diabetes. The Benaroya Research Institute (BRI) Clinical
Center has been a highly collaborative partner in both the consortium as a whole and in the DREAM study in
particular. Our investigators lead the consortium’s Immunology Working Group and are members of the
Pancreatitis, Diabetes, Recruitment and Retention, Biospecimens, Publications, and Protocol Writing Groups.
We helped develop the study protocol and its aims, and since the study was initiated have been one of the
highest recruiting centers with 92 participants enrolled to date. We have a high rate of retention into long term
follow-up and were among the first sites to see a participant at 3 years of follow-up. Here, we propose to continue
and extend our efforts in support of this study via the following 2 aims. AIM 1: Complete follow up visits for all
DREAM participants at the BRI T1DAPC Clinical Center, enabling the DREAM study to address its primary
outcome of defining the frequency and characteristics of DM development after AP. AIM 2: Discover and validate
immune signatures associated with resolution of AP and development of DM.

Public health relevance
PROJECT NARRATIVE Acute pancreatitis remains a sizeable public health problem, accounting for over 300,000 hospitalizations, with US healthcare costs estimated at over $2 billion; the frequency and characteristics of diabetes developing after acute pancreatitis have been relatively poorly described. As one of 10 clinical centers in the Type 1 Diabetes after Acute Pancreatitis Consortium, we have enrolled 92 participants into a multi-center longitudinal study of the development of diabetes after acute pancreatitis. Here, we plan to perform the protocol-defined long-term follow- up of these participants that is needed to characterize the endocrine and immune changes that evolve after acute pancreatitis.